Impact of Host NF-kB Signaling in Radiation Therapy

PROJECT SUMMARY / ABSTRACT
Investigation of cytoplasmic-to-nuclear (C→N) NF-κB signaling pathways induced by various cell surface
receptors has significantly expanded the knowledge regarding the role of this transcription factor family in
regulating immune/inflammatory responses and tumorigenesis. By contrast, the physiological role of DNA
damage-induced nuclear-to-cytoplasmic (N→C) NF-κB signaling remains poorly understood. The proposed
study will fill this knowledge gap by elucidating a surprising and crucial role of N→C NF-κB signaling in sustaining
anti-tumor CD8 T cell responses during radiotherapy (RT) in vivo. The current proposal utilizes a genetically
modified mouse model that selectively disables N→C NF-κB signaling in vivo. Our preliminary data show that
radiation therapy can induce sustained regression of syngeneic tumors in a manner dependent on CD8 T cells.
We also found that a special type of memory CD8 T cells implicated in tumor control is expanded in this mouse
model. Finally, we have generated an encouraging data with an NF-kB DNA binding inhibitor to induce sustained
tumor regression following radiation therapy. Based on these observations, we hypothesize that inhibition of
N→C NF-κB signaling in the host improve radiation therapy via generation of tumor antigen-specific memory
CD8 T cells. We will test this hypothesis by define the cellular mechanism of sustained tumor control mediated
by inhibiting host N→C NF-κB signaling in radiation therapy (Aim 1), elucidate the molecular mechanism of
sustained tumor control mediated by inhibiting host N→C NF-κB signaling in radiation therapy (Aim 2) and target
host N→C NF-κB signaling with a chemical inhibitor to improve radiation therapy (Aim 3). The proposed study is
significant because the physiological role of N→C NF-κB signaling in modulating host tumor response is
completely undefined and this study will fill this knowledge gap. It is innovative because a new mouse model and
a novel chemical inhibitor currently undergoing Phase 2 clinical trials will be employed. Finally, a high impact is
expected because chemical targeting of N→C NF-κB signaling by the above inhibitor may expedite timely
translation to clinical trials.

Public health relevance
PROJECT NARRATIVE Ionizing radiation is used to treat a large fraction of cancer patients with variable success rates. Radiation can cause immune cell-mediated cancer cell killing but mechanisms are not fully understood. This study will reveal a new mechanism that will improve radiation therapy efficacy and durability through generation of a special kind of memory T cells that are capable of killing cancer cells. It will also test and optimize the use of a novel drug to improve efficacy and durability of radiation therapy. If successful, this study may lead to clinical trials using the drug that has successfully undergone a Phase 1 clinical trial to demonstrate safety for patient use.